MAPPING PROTEIN DISTRIBUTIONS IN EPIDERMIS BY ELECTRON ENERGY LOSS SPECTROSCOPY

To understand the changes undergone by squamous epithelial cells during terminal differentiation, it is important to determine distributions of key proteins at successive stages. As a complement to immuno-cytochemistry, we have performed EM-based elemental mapping of sulfur and nitrogen in newborn mouse epidermis and forestomach. Energy-filtered transmission electron microscopy (EFTEM) images reveal high sulfur concentrations in round cytoplasmic granules and in the cornified cell envelope (CE), correlating with loricrin (about 6% cysteine). Electron energy-loss spectroscopy (EELS) analysis confirms these observations, supporting the inferred precursor-product relationship between L-granules and the CE. Other deposits near the epidermal CE have a similar sulfur content, but do not label with antiloricrin antibodies, thus suggesting the presence of another S-rich protein.